Dissecting connections between diet, the microbiome and Alzheimers disease

Project Summary/Abstract
Our population is aging. As our population ages, the incidence of Alzheimer’s Disease (AD), an age-associated
illness, grows, resulting in elevated health care costs. A second factor contributing to the current rise in age-
associated aliments is the American diet with its ever-increasing amount of added sugar. The negative effects of
added dietary sugar is in part due to advanced glycation end products (AGEs) which form from the process of
glycation where a sugar molecule attaches to a protein or lipid without enzymatic regulation thereby altering its
structure and/or function. AGEs form in normal metabolism but when AGEs rise to high levels in tissues and
circulation, as in diabetes or high dietary sugar, they can become pathogenic since AGEs promote oxidative
stress and inflammation. A third contributor to the increases in AD is the microbiome; recent studies have linked
age-associated illness with changes in the microbiome. The central unifying hypothesis of this proposal is that
consumption of a sugar-loaded diet alters the microbiome and contributes to the onset and severity of AD. We
will address this hypothesis with two specific aims using a Caenorhabditis elegans–Escherichia coli system.
Our experimental C. elegans–E. coli paradigm is an excellent system for these studies because: (1) C. elegans
are bacterivores and have an obligatory symbiotic relationship with microbes as their food source, which
becomes the intestinal microbiota; (2) C. elegans possess stress and immune signaling pathways that are
evolutionarily conserved; (3) Genetic tools are available including transgenic strains for AD whereby human β-
Amyloid precursor protein (Aβ peptide) is driven by a tissue specific promoter. (4) We can modify the environment
(added sugar) resulting in changes in the levels of dietary AGEs(dAGEs); and (5) Our preliminary data show
when C. elegans consume live (microbiota) or heat killed (no microbiota) sugar-loaded high- dAGE E. coli, C.
elegans have a shortened lifespan and reduced healthspan. Our results also demonstrate the importance of
the microbiota as a buffer for stress. In Specific Aim 1, we will address the effects of a sugar-loaded high-dAGEs
diet on AD transgenic animals with heat killed or live bacteria. In Specific Aim 2, we use a series of genetic tools,
(including mutants, transgenics)to provide mechanistic insight. This proposal exploits a symbiotic relationship to
define how a sugar loaded/high dAGEs diet promotes Aβ accumulation. Our results in the two- year period could
be paradigm shifting in our understanding of the impact of added dietary glucose on AD. The long-term goal is to
modify diet to delay or even eliminate the onset of AD.

Public health relevance
Project Narrative As our population ages, the incidence of Alzheimer's disease increases, adding economic and social stress. Here, we seek to dissect how consumption of a sugar-loaded diet alters the microbiome and contributes to the onset and severity of Alzheimer's disease with a long-term goal of using diet as an intervention for Alzheimer's disease.